2023 Physiology, Biology and Pathology of Phosphate GRC

Project Summary/Abstract
The 2023 Gordon Research Conference (GRC) “Physiology, Biology and Pathology of Phosphate” will provide
cutting edge science and stimulate inter-disciplinary collaborations to facilitate a better understanding of the
complexity of normal and pathologic phosphate regulation. This integration, or full understanding, or the systems
biology that control this mineral is needed if we are to understand both normal physiology and regulation in
different disease states. Investigators that study intestine, kidney, parathyroid glands and bone, each with both
unique and common pathways for sensing, signaling, and responding to changes in phosphate concentrations
will come together to share new discoveries. These scientists do not normally interact given the diversity of
organs involved, and thus this GRC will provide a forum that facilitates scientific exchange among diverse
scientists from around the world, working across the translational spectrum and from all career stages. The
number of overall participants will be capped at 200 to ensure an environment conducive to friendly exchange,
social interactions that facilitate collaborations, and conversations that propel the field forward. The program will
have 25 talks organized into nine morning and evening sessions entitled 1) Overview of Phosphate in Health
and Disease, 2) Organs Contributing to Phosphate Homeostasis and Endocrine Regulators, 3) Disorders of
Phosphate Homeostasis, 4) Organ Crosstalk in the Regulation of Phosphate Balance, 5) Phosphate Sensing,
Uptake, Signaling and Effects in cells, 6) Pathologic Effects of Phosphate on Cells, 7) Biology of Phosphate
Containing Complexes 8) Measurements and Models, 9) The Intestinal Environment and Regulation of
Phosphate Absorption. In each session, selected posters will be presented orally and there will be a facilitated
discussion. Poster sessions will be held each day and purposely place investigators from different fields adjacent
to each other to facilitate conversation and exchange of methods and ideas to build collaborations. The meeting
will also have a “power hour” to focus on the challenges facing women in science, moderated by Co-Chairs and
GRC staff. Additional small group opportunities that engage pre and post docs with senior faculty will be
organized to provide career advice, identify potential mentors or sponsors, and facilitate collaborations. In
summary, this inaugural GRC focusing on the cellular effects and regulation of phosphate homeostasis will
facilitate cross-disciplinary collaborations and encourage trainees that the future of this field is exciting.

Public health relevance
Project Narrative Phosphate is an essential mineral for healthy bones and cellular processes and is controlled by multiple organs in the body to maintain homeostasis and balance. However, in many disease states, abnormal function of one of the controlling organs (for example intestine or kidney) can lead to systemic manifestations that threaten normal growth and metabolism. The 2023 Physiology, Biology and Pathology of Phosphate GRC will facilitate scientific exchange among diverse scientists to discuss these topics and share information with the goal of working towards better understanding these systems.